Parent-child proximity and emerging psychopathology

PROJECT SUMMARY/ABSTRACT
The caregiving environment children experience is the most important modifiable feature for shaping brain
development and influencing subsequent mental health. Building from knowledge of infant mental health and
developmental neuroscience, this NIMH BRAINS award application is designed to advance our understanding
of how children’s experiences with their caregivers during infancy, a developmental period characterized by
heightened brain plasticity, influences brain and behavioral development. Specifically, we will use innovative
methods to characterize multiple aspects of the early caregiving environment in relation to changes in brain
structural and functional connectivity that are believed to contribute to the onset of mental disorders. The
application of new tools, coupled with traditional metrics, will improve our measurement of children’s
experiences using a child-centered approach (i.e., capturing children’s contact with multiple caregivers). To do
this, we will recruit 150 women in pregnancy and, following birth, conduct assessments in children’s daily
ecological context at ages 1, 6, 12, and 18 months. This project introduces a wearable device technology that
can dynamically, unobtrusively, and continuously measure patterns of physical proximity between children and
caregivers, regardless of physical location. In addition to children’s proximity to caregivers, we will obtain
ecological assessments of language exposure and observation-based caregiver sensitivity and examine the
convergence and divergence among these different ways of capturing children’s experiences (Specific Aim 1).
While prior research suggests that greater environmental enrichment leads to lower symptoms of
psychopathology, the lack of granularity in measurement (i.e., not capturing the full continuum of relative
psychosocial neglect–enrichment) has precluded the ability to characterize the shape of these associations
(e.g., linear, nonlinear). We will study children selected to range in experiences along the neglect–enrichment
continuum and use repeated neuroimaging of infant brain structural and functional connectivity and repeated
behavioral assessments to explore the possible profile of the associations between aspects of the caregiving
environment and changes in brain and behavior (Specific Aim 2). Last, we will examine how changes in
emotion regulation and emotion reasoning circuitry are associated with signs of emerging psychopathology at
age 18 months in order to test whether, when, and how variations in early experience influence risk for
psychopathology through changes in emotion-related circuitry (Specific Aim 3). Here, neuroimaging is
particularly advantageous as it allows us to examine the maturation of emotion-related networks from birth and,
importantly, prior to the onset of detectable mental health difficulties. Achievement of the aims of this proposal
is expected to meet NIMH’s objectives to determine the biological and psychological mechanisms by which
experience affects neural and behavioral development, with direct applications for prevention and early
intervention.

Public health relevance
PROJECT NARRATIVE Given the foundational importance of early brain development for subsequent psychopathology, it is imperative to capture children’s everyday experiences with their caregivers in relation to changes in infant brain development. Addressing the need for more ecologically-valid approaches to our understanding of children’s early experiences, this study uses a newly developed wearable device that can dynamically, unobtrusively, and continuously measure patterns of physical proximity between children and caregivers, regardless of location. The proposed project will yield extraordinary insight into the early environment from a child-centered perspective during the first 18 months of life, with relevance to NIMH’s mission to determine the biological and psychological mechanisms by which the environments affect neural and behavioral development.